Regulation of Cerebral Blood flow by Intrinsic Neuromodulation in Wakefulness and Sleep

PROJECT SUMMARY
Noninvasive functional imaging techniques, such as functional Magnetic Resonance Imaging (fMRI), have a
potential for diagnosing neurological diseases and evaluation of treatments. However, to fully realize this
potential, we need better understanding of the process known as neurovascular coupling (NVC). My recent study
in mice revealed that, during resting state, hemodynamic fluctuations depend on norepinephrine (NE), an intrinsic
vasoactive neuromodulator. Using my experimental measurements, I derived a simple model that predicted
hemodynamics across the cerebral cortex with high accuracy given a measure of NE and local circuit activity.
The proposed study aims to extend these results to other brain states and neuromodulatory neurotransmitters.
In Aim 1, I will use widefield imaging of the entire dorsal cortical surface to image neural calcium activity, release
of a neuromodulator (ACh, NE, DA, or 5-HT), and fluctuations in oxy/deoxy/total hemoglobin. These optical
measures, together with EMG and µECoG recordings, will be used to label brain state, which will be used to
relate fluctuations in neuromodulator release to brain state-specific hemodynamics. Then, for each brain state, I
will identify and formalize the dependence of hemodynamics on the relevant neuromodulatory neurotransmitters
in terms of the Impulse Response Function (IRF) used in fMRI studies.
My Aim 2 is a mechanistic counterpart of Aim 1. In Aim 2, I will evaluate the causal relationship between the
release of a specific neuromodulator and hemodynamic fluctuations across brain states. To this end, I will use
two-photon microscopy to measure dilation of single cortical arterioles simultaneously with neural calcium activity
and neuromodulator release. I will use pharmacological tools and opto/chemogenetics to block the receptors or
neuromodulatory release while simultaneously tracking brain state transitions.
The results of this project will (a) deliver new mechanistic knowledge about the regulation of cerebral blood
flow by neuromodulation, across brain states, and (b) inform the choice of IRF in fMRI studies. Beyond
the current scope, these results would allow asking the question of whether release of specific neuromodulators
can be predicted from noninvasive hemodynamic signals, something that I am interested to explore during my
future postdoctoral training.
For my long-term career, I intend to apply engineering principles to neuroscience questions and combine
mechanistic animal studies with computational modeling, as a leader of a research group in an academic
institution. The goal of my training plan is to (1) expand my scientific knowledge base in neurophotonics and
computational neuroscience, (2) develop novel concepts about specific mechanisms that govern neurovascular
coupling and generation of hemodynamic signals, (3) present my results at international forums and produce
high-profile publications, and (4) expand a network of colleagues and collaborators.

Public health relevance
PROJECT NARRATIVE This predoctoral fellowship project applies a quantitative, bioengineering approach to a key neuroscience question about the regulation of cerebral blood flow by neural activity. Proposed research will contribute to an informed interpretation of noninvasive brain imaging and deliver mechanistic understanding needed for studies of neurological disease, where a deterioration of neurovascular physiology contributes to motor and cognitive decline. This fellowship will offer the applicant an invaluable training opportunity facilitating his career development as a future independent investigator.